Improving red blood cell storage for trauma resusciation

Project Summary
The long-term goal of our research is to increase our understanding of the mechanisms by which
transfusion of stored pRBC units harms trauma patients and to mitigate these effects through improved
pRBC storage. Trauma is the leading cause of death worldwide for those under 44 years of age.
Hemorrhage accounts for 30-40% of these fatalities and is the most common potentially preventable cause
of death from trauma. Survival after hemorrhage is dependent on surgical control of bleeding followed by
resuscitation with red blood cells to replace intravascular volume and correct anemia. Packed red blood
cells develop a series of biochemical and physical changes during storage that is collectively termed the red
blood cell storage lesion. While there is no substitute for blood, rapid use of multiple units of aged red blood
cells for resuscitation is harmful in severely injured patients, including increased multisystem organ failure,
pneumonia, renal failure, sepsis, and death. Our previous work demonstrates that red blood cell units
contain microparticles that mediate inflammatory events after hemorrhage and resuscitation and that
decreasing their effect leads to a blunted inflammatory response and lung injury. Our data has also
demonstrated that components of stored packed red blood cells lead to endothelial cell and leukocyte
activation with resultant lung injury and microvascular thrombosis. We have confirmed that intervention to
correct aspects of the red blood cell storage lesion and its effects leads to decreased harm after
hemorrhage and resuscitation. We have also developed data that indicate that advanced glycation end
products form during red blood cell storage and that a significant portion of the inflammatory response to
resuscitation with older packed red blood cell units is mediated by the receptor for advanced glycation end
products. We have also demonstrated that improvements in the storage environment and storage solutions
will mitigate aspects of the red blood cell storage lesion. These findings, as well as the clinical need for
improved packed red blood cells for resuscitation, have led us to propose two projects. Project 1 will seek
to attenuate advanced glycation end product formation during packed red blood cell storage and the
resulting effects during resuscitation after hemorrhage. Project 2 seeks to develop novel storage solutions
to improve the quality of stored red blood cell units. With increased recent emphasis on the use of blood
products for resuscitation from hemorrhagic shock, there is a crucial need to improve our understanding of
the red blood cell storage lesion as well as potential strategies to mitigate harm from massive transfusion of
older red blood cell units. If successful, the proposed work will address key gaps in our knowledge and
clinical practice regarding a mechanistic understanding of the development and impact of the red blood cell
storage lesion on the recipient during resuscitation as well as the need for novel storage solutions to
attenuate the storage lesion and mitigate harm from massive transfusion of older pRBC units.

Public health relevance
Project Narrative Hemorrhage is a major cause of death in injured patients. Resuscitation with stored packed red blood cells may cause harm to patients who survive. The proposed experiments will increase our understanding of how to mitigate harm from the use of packed red blood cells during resuscitation after trauma and hemorrhage.